Genome instability associated with oncogene amplification and its therapeutic strategy

PROJECT SUMMARY
Focal oncogene amplification (OA) is a common driver of cancer and is linked to early relapse, poor survival,
and treatment resistance. Despite the success of anti-HER2 therapy in HER2-amplified breast cancers, targeting
amplified oncogenes remains challenging in many cancer types. The molecular mechanisms underlying these
aggressive clinical features are poorly understood, which hampers the development of effective therapies
targeting OAs. Preliminary data reveal extensive intratumoral heterogeneity in cases with focal OA. The genomic
rearrangements and subclonal copy-number alterations observed post-OA suggest that cancer cells follow
divergent evolutionary paths, rather than proliferating uniformly. This may distinguish OA from other cancer driver
events and explain the links to adverse clinical outcomes. The primary hypothesis of this proposal is that the
mutational processes amplifying oncogenes induce genome instability through structural rearrangements,
facilitating the evolution into therapy-resistant clones. This hypothesis will be tested in cohorts of patients with
breast and lung cancers, where OAs are prevalent, clinically relevant, and develop through distinctive
mechanisms. Single-cell whole-genome sequencing will be employed to detect cell-to-cell genomic variations
and will be jointly analyzed with long-read sequencing and single-cell RNA sequencing. Specifically, the study
will: 1) Differentiate the mechanisms by which OA leads to genome instability, distinguishing structural instability
(causing genomic rearrangements) from phenotypic instability (overexpressed oncogenes causing mitotic errors)
2) Identify DNA repair pathways that enable OA-driven clonal evolution and their interactions with the cell cycle,
and 3) Investigate the role of OA-associated genome instability in the development of therapy-resistant clones
by leveraging a new cell-free DNA assay detecting subclone-specific genomic rearrangements. Furthermore,
synthetic lethal strategies to prevent OA-driven clonal evolution before the emergence of therapy-resistant clones
will be evaluated in lung cancer cell lines and patient-derived xenograft models. DNA double-strand break repair
pathways will be tested as therapeutic targets to mitigate OA-associated genome instability and therapy
resistance. These studies aim to provide insights into the mechanisms underlying adverse clinical outcomes
associated with OAs and propose new therapeutic strategies for OA-driven cancers, addressing significant
clinical needs. The applicant, Dr. June-Koo Lee, a Medical Oncology Fellow at Memorial Sloan Kettering Cancer
Center (MSK), has outlined a five-year career plan under the mentorship of Drs. Sohrab Shah and Charles Rudin,
experts in cancer evolution and lung cancer, respectively. Dr. Lee will develop expertise in 1) single-cell analyses,
2) plasma cell-free DNA assays, and 3) patient-derived xenograft experiments. His advisory committee will guide
his training and research. MSK provides the ideal support for Dr. Lee to transition into an R01-funded tenure-
track physician-scientist role, focusing on clonal evolution mechanisms and their clinical implications.

Public health relevance
NARRATIVE Oncogene amplification is common in human cancers and is associated with adverse clinical outcomes and therapy resistance in multiple cancer types. Based on preliminary data, we hypothesize that this results from unique mechanisms of oncogene amplification, causing genomic rearrangements and thereby leading to heterogeneity in the cancer cell population. Using single-cell whole-genome sequencing, gene expression analysis, long-read sequencing, and circulating tumor DNA assays, we aim to elucidate the mechanistic links between oncogene amplification, genome instability, and therapy resistance, and to evaluate therapeutic strategies to reduce oncogene amplification-induced genome instability and prevent the evolution into therapy-resistant cancer cells.